Improving response durability after CAR T cell therapy for multiple myeloma

PROJECT SUMMARY / ABSTRACT (PROJECT 3)
Multiple myeloma (MM) is a hematologic malignancy of bone marrow plasma cells. Even though MM is almost
universally fatal, modern therapy has markedly improved survival. Among the most promising new MM therapies
are CAR T cells targeting B cell maturation antigen (BCMA). Despite high response rates in patients with
advanced disease, however, almost all patients eventually relapse after current-generation anti-BCMA CAR T
cells. This proposal furthers a long-term goal to prevent late relapse in MM patients after initial response to CAR
T cell therapy. In most cases, BCMA expression is retained at relapse, suggesting loss of anti-BCMA immune
surveillance as the primary mode of treatment failure. We and others have found that features of the T cells used
for CAR T cell manufacturing predict clinical outcomes, that CAR T cells can occasionally proliferate at late
timepoints post-infusion to control progressive disease, and that features of the bone marrow microenvironment
predict relapse risk after anti-BCMA CAR T cells. This proposal undertakes new approaches to prevent late MM
relapse after CAR T cell therapy; the approache to the clinical and pre-clinical studies is rooted in these prior
observations. We will conduct a clinical trial to test the safety and feasibility of therapy with anti-BCMA CAR T
cells manufactured from marrow-infiltrating lymphocytes (MIL) rather than the peripheral blood lymphocytes
traditionally used in CAR T cell manufacturing. We hypothesize that the BM-homing capability of MILs will
enhance trafficking and persistence of CAR T cells in BM. We will also pre-clinically develop two new approaches
to modulate CAR T cell activity in vivo post infusion. (1) We will introduce a modified IL-2 receptor into CAR T
cells to enable selective post-infusion in vivo stimulation with a pharmacologically administered and orthogonally
modified IL-2 ligand (orthoIL2); we hypothesize that orthoIL2 can prevent late relapse by maintaining in vivo anti-
BCMA immune surveillance. (2) We will develop BCMA-encoding mRNA-containing lipid nanoparticles (mRNA-
LNPs) to present BCMA in the context of antigen-presenting cells outside the immunosuppressive MM
microenvironment; we hypothesize that BCMA-encoding mRNA-LNPs can prolong in vivo anti-BCMA immune
surveillance, providing an approach to post-infusion modulation of CAR T cell activity that could be rapidly and
cost-effectively translated in combination with established, FDA-approved anti-BCMA CAR T cell therapies.
Collectively, our proposed studies will generate clinical and pre-clinical data to support the development of early-
phase clinical trials promising new approaches to prevent relapse after CAR T cell therapy for MM, which is the
primary clinical problem facing the field. In addition, findings from our studies could be readily translated to other
cancer types, including solid tumors.

Public health relevance
PROJECT NARRATIVE (PROJECT 3) This project is relevant to public health because it evaluates new strategies to improve duration-of-response to CAR T cell therapy in multiple myeloma patients, a largely incurable blood cancer for which current-generation CAR T cells are only partially effective. The project is relevant to those parts of the NCI's mission that pertain to eliminating suffering and death due to cancer. This work is expected to open new therapeutic approaches in the field of adoptive immunotherapy for multiple myeloma and new research horizons that could be translated to other malignancies.